Health Promotion and Disease Prevention Research Center

SUMMARY ABSTRACT
Breast and cervical cancer are common and contribute significantly to cancer-related mortality for women.
Rates of breast and cervical cancer screening are particularly low among low income and minority
populations. The Centers for Disease Control and Preventions National Breast and Cervical Cancer Early
Detection Program (NBCCEDP) aims to address these disparities by providing access for breast and cervical
cancer screening through direct screening services and through implementation of community clinical linkage
(CCL) interventions to connect unscreened and difficult to reach populations of women to high quality
screening services. We will systematically identify two to three promising CCL interventions currently in use
by NBCCEDP Grantees (Grantees). Guided by the CDC Evaluation Framework we will partner with the
selected Grantees implementing promising CCLs to implement rigorous effectiveness and cost- effectiveness
evaluations to determine the degree to which CCL interventions increase screening among unscreened and
difficult to reach populations. We will also assess the scalability of the CCL interventions. Our findings will
provide evidence about key components of CCL interventions, and suggest interventions for future scale-up
and spread to reduce the burden of breast and cervical cancer screening.

Public health relevance
PROJECT NARRATIVE The purpose of SIP 19-006 “Evaluating Community Clinical Linkage Interventions in the National Breast and Cervical Cancer Early Detection Program (NBCCEDP)” is to identify and evaluate the effectiveness, cost- effectiveness, and scalability of two to three Community Clinical Linkage (CCL) interventions used by NBCCEDP Grantees to increase breast and cervical cancer screening in unscreened and difficult to reach populations. Our team developed a conceptual model to guide effectiveness measurement, and we will use the CDC Evaluation Framework to guide design of a rigorous and pragmatic evaluation strategy to implement the evaluations in partnership with two NBCCEDP Grantees. Our findings will contribute important knowledge about the effectiveness and cost-effectiveness of CCL interventions across the cancer continuum.